Feasibility and design of a novel smartphone app to deliver blood pressure-lowering inspiratory muscle strength training

PROJECT SUMMARY
High blood pressure (BP), particularly high systolic BP (SBP), is the major modifiable risk factor for
cardiovascular diseases (CVD) and related conditions. Indeed, over 50% of all adults have above-normal
SBP (≥120 mmHg), placing them at increased disease risk. In addition, these adults face ~$2000/year in
excess medical expenses compared to their peers with normal BP. Rates of BP control in the United States
are worsening, predicting a new epidemic of disorders driven by above-normal SBP, and an increasing
financial burden for those affected, unless innovative and affordable therapies with clinical efficacy can be
adopted by, and translated to, this at-risk group.
High-resistance inspiratory muscle strength training (IMST) is a novel lifestyle intervention involving
repeated inhalations against resistance with a hand-held device. In a randomized, double-blind, sham-
controlled, R21-funded study in adults with above-normal SBP (n=36), we found that IMST (30 breaths/day [~5
min/day] at 75% maximal inspiratory pressure [PIMAX], 6 days/week for 6 weeks) had excellent adherence
(94% of prescribed training sessions completed), increased inspiratory muscle strength (~20% increase in
PIMAX) and lowered SBP by 9 mmHg compared to low-resistance sham training – thus establishing the clinical
efficacy of high-resistance IMST. Importantly, this 9-mmHg reduction in SBP compares favorably to time-
intensive lifestyle strategies (e.g., aerobic exercise) and pharmacotherapy, without the side effects associated
with medication. However, this trial was performed in the research clinic. Therefore, the next step in the overall
translation of IMST for improving public health is to establish a vehicle to disseminate IMST instruction and
promote intervention adherence by utilizing digital health technologies and creating a smartphone app.
In this Phase I STTR application, we propose to begin the process of developing a smartphone app for
commercialization that independently guides users through an IMST intervention for lowering SBP and
reducing disease risk and the associated financial burden. This will be accomplished through 3 specific aims:
Aim 1: Conduct iterative focus groups with adults who have above-normal SBP to collect potential user
information for IMST smartphone app needs and preferences;
Aim 2: Finalize the conceptual model and develop planned app components including printed wireframes,
storyboards, and clickable wireframes; and
Aim 3: Conduct beta testing on the clickable wireframes and finalize app design.
Successful completion of the above aims will position us to develop the fully programmed high-resistance
IMST smartphone app and apply for Phase II STTR funding to conduct a randomized clinical trial assessing
the effectiveness of at-home IMST with the app for lowering SBP. Ultimately, our app will fill an unmet need in
the marketplace by delivering an effective, adherable, cost-saving, BP-lowering intervention.

Public health relevance
PROJECT NARRATIVE Above-normal systolic blood pressure (SBP; ≥120 mmHg) is associated with an increased risk for cardiovascular diseases. We recently established the clinical efficacy of high-resistance inspiratory muscle strength training (IMST), a novel form of physical training with minimal barriers to adherence, for lowering SBP in a clinical trial with regular clinic-based, researcher-supervised training. This Phase I STTR application seeks to leverage the growing field of digital health technologies by taking the first steps in developing a feasible and acceptable smartphone app for commercialization that independently guides users through a high-resistance IMST program, a key step to translate IMST for widespread use and improving public health.